Advancing community-driven optimization for implementation of early childhood mental health prevention in pediatric learning health systems: Mental Health, Earlier ALACRITY Research Center

This Center strategically addresses a key developmental driver of the youth mental health crisis: Currently, 1 in 5 children have an identified mental health problem as early as age 3. This Mental Health, Earlier ALACRITY Implementation Science Research Center addresses the grand challenge of achieving population-level impact of early childhood mental health prevention efforts within routine pediatric care, a promising setting for achieving population impact. The Center is Northwestern based, including longstanding partnerships with Lurie Children’s Hospital, community health centers within Nemours Children’s Health and AllianceChicago’s practice-based research network, and University of Utah Health. The Center’s connective thread is a novel implementation framework, human-centered design methods, and a novel Roll-Out Implementation Optimization trial design, which systematically engages partners in strategy optimization. Center Aims: (1) Develop novel caregiver-focused, system-, and clinician-level strategies to advance implementation of developmentally- and ecologically-grounded early mental health screening and interventions in pediatric primary care; (2) Address the unique needs of varied communities and families via engagement in tailored evidence-based prevention services; and (3) Create a national resource for implementation of childhood mental health innovation in pediatric primary care, including fostering a cadre of scientific and workforce leaders and experts, and an open access toolkit. Center Signature Project (Peds-BRITE) and four Research Projects (RPs) innovate, implement, and integrated evidence-based interventions and strategies, with RPs testing novel approaches and/or levels of inquiry designed to address recognized, but understudied, barriers; Pediatricians Building Resilience through early Identification for Toddler Well-Being (Peds-BRITE): This cluster randomized trial implements an evidence-based toddler mental health risk decision tool with coordinated care to the Family Check-Up Online to support parenting and toddler self-regulation; Talking Early About Mental Health for Access (TEAM4Access): Deploys digital case-based training to improve clinician confidence and family-centered communication about toddler mental health risk for families from varied backgrounds and communities; Supporting Parent Action for Resilient Kids: A Single-Session Intervention to Boost Caregiver Adoption of Early Childhood Mental Health Services (SPARK): Adapts an evidence-based adjunctive digital single-session intervention to increase families’ mental health services use; Researching Ethics and Assessment of Unintended Consequences in Healthcare for Mental Health Earlier (REACH4MHE): Explores unintended consequences of early mental health prevention via an integrated bioethical-implementation framework. Community & Scientific Engagement & Administrative- and Methods Incubation Cores provide vision, coordination, methodologic and career development supports to advance implementation of early mental health promotion across a range of pediatric primary care systems and families.

Public health relevance
This Mental Health, Earlier ALACRITY Center addresses a key development driver of the youth mental health crisis: 1 in 5 children have a mental health diagnosis by the age of 3 but existing evidence-based tools and approaches have failed to be systematically implemented in routine primary. To achieve population reach, the proposed Center advances scalable approaches to pediatric primary care-based early mental health promotion via targeting toddler transdiagnostic behavioral vulnerability at the preclinical phase to impact lifespan mental health. The Center’s unique implementation framework, tools and strategies are poised to foster mental health, promote resilience, and reduce the public health burden of early-onset severe mental health problems for children and families with varied lived experience, with innovations including digitally delivered prevention for increased access, ongoing integration of community partner priorities and values, interactive provider training to improve confidence in developmentally-based decision making and accessible strategies for bridging the screening to services gap via heightened family engagement.